Ultrasensitive, High-Specificity Rapid Test to Support the End-Game of the Global Program to Eliminate Lymphatic Filariasis

PROJECT SUMMARY / ABSTRACT
Here we propose a rapid, field-deployable, cost-effective, highly sensitive and specific lateral flow assay (LFA)
that meets all the requirements recently defined by the World Health Organization (WHO) in a target product
profile (TPP) for surveillance activities of Lymphatic Filariasis (LF). LF is a disfiguring and debilitating neglected
tropical disease that affects 40 million people in 72 countries and is due to the parasitic filarial worm Wuchereria
bancrofti. To combat this disease, WHO has deployed mass drug administration (MDA) programs globally on an
unprecedented scale. Today, WHO recommends repeating transmission assessment surveys (TAS) twice in 2- to
3-year intervals after MDA cessation, while acknowledging that more research is urgently required to improve
diagnostic tests for TAS and post-treatment surveillance (PTS) until 2030, and beyond. In March 2021, WHO has
published a TPP for the test it seeks, where the key requirements are that the test should be able to detect early
infection, have >85% clinical sensitivity and > 98.8% specificity.
The only proven field-deployable tests for LF are the immunochromatography testcard (ICT) and its subsequent,
more stable version, the Filariasis Test Strip (FTS). These tests have been used for 2 decades to detect active
infections. However, they are not suited for surveillance activities, as they detect the disease only 18 months
after a person has been infected and lack sensitivity in post-MDA settings due to low parasite burden.
According to the WHO TPP, LF surveillance requires an RDT indicative of early exposure to W. bancrofti infective
larvae (L3 stage). Currently, the best biomarker to this effect are IgG4 antibodies specific for the Wb123 antigen
expressed by infective larvae. A commercial IgG4/Wb123 ELISA exists (inBios) and is routinely used at the Centers
for Disease Control and Prevention (CDC) but is not field-deployable. A portable rapid test was introduced by
Standard Diagnostics, now part of Abbott, but fell short of the expected sensitivity and was abandoned (SD
BIOLINE Wb123 IgG).
We have recently succeeded in developing an LFA prototype for the detection of Wb123-specific IgG4 which is
characterized by an analytical sensitivity 16-32 greater than that of the Abbott RDT and equal to the commercial
Wb123 ELISA. We view this as a major achievement. This test is poised to meet the > 85% clinical sensitivity
criterion. However, it is not clear if it will also meet the minimal (>98.8%) or ideal (>99.8%) specificity criterion.
We now propose a biplex test allowing to simultaneously detect antibodies against two antigens, of which one
will be Wb123, and the other one chosen from a series of five novel antigens, termed WbAg1-5 or WbAgX. The
purpose of the dual test is to achieve a superior specificity by imposing the condition that both test lines must
be visible to count the test as positive, and no line must be visible for the test to be counted as negative.
We have been awarded a grant from the Task Force for Global Health (TFGH) and USAID to develop a prototype
version of such a biplex assay. We are now requesting additional funding from the NIH to (1) optimize one or
more biplex assays (2) establish a biorepository of 2000 clinical samples to demonstrate that the TPP meets the
required sensitivity and specificity with > 95% statistical confidence and (3) progress one biplex to manufacturing
and commercialization. By the end of this Phase I/II Fast-Track grant, a total of 100,000 assays will be available
for testing by the TFGH, the CDC, and other stakeholders to generate the field data necessary to secure its
international endorsement. The developed manufacturing process will be able to meet the estimated demand
of 0.5-1 million assays/year at a cost point acceptable to the sponsoring agencies.
It is noteworthy that USAID, which is the largest customer for LF tests worldwide, covering over 40% of the global
demand, has already sponsored our initial research, showing their interest, and providing a clear path to
commercialization. In short, our RDT will thus be poised for the surveillance of lymphatic filariasis, a disease that
figures prominently on the WHO’s 2030 roadmap for Neglected Tropical Diseases, and which the international
community, supported by major pharmaceutical companies and NGOs, has vowed to eliminate in the 2012
London Declaration.

Public health relevance
PROJECT NARRATIVE Here we propose a rapid, field-deployable, cost-effective, highly sensitive and specific lateral flow assay (LFA) that will fully meet a Target Product Profile (TPP) released in 2021 by the World Health Organization (WHO) for the surveillance of Lymphatic Filariasis (LF). The filarial worm Wuchereria bancrofti, the main causative pathogen of lymphatic filariasis (LF), has been the focus of the most ambitious mass drug administration (MDA) programs ever implemented by WHO. With 50 countries theoretically approaching disease elimination in the next 5 years, there is an urgent need for new and sensitive field-deployable diagnostics that will assist countries in conducting post-MDA surveillance until 2030, and beyond. The key requirements of the TPP are that the test should be able to detect early infection, have >85% clinical sensitivity and > 98.8% specificity, and be field-deployable and cost-effective. To date, the best markers of early infection are IgG4 antibodies the human host generates in response to Wb123, a protein expressed by the infective (L3) stage of W. bancrofti. The only existing IgG4/Wb123 portable Rapid Diagnostic Test (RDT), marketed by Abbott, had a clinical sensitivity around ¼ that of the corresponding ELISA. In earlier work, we have developed a prototype LFA for the detection of Wb123-specific IgG4 characterized by an analytical sensitivity 16-32 greater than that of the Abbott RDT and equal to the commercial Wb123 ELISA. This test is poised to meet the > 85% clinical sensitivity criterion but might fall short of the minimal (>98.8%) or ideal (>99.8%) specificity criterion. We now propose a biplex test allowing to simultaneously detect antibodies against two antigens, of which one will be Wb123, and the other one chosen from a series of five novel antigens, termed WbAg1-5 or WbAgX. The purpose of the dual test is to achieve a superior specificity by imposing the condition that both test lines must be visible to count the test as positive. We have been awarded a grant from the Task Force for Global Health (TFGH) and USAID to develop a prototype version of such a biplex assay. We are now requesting additional funding from the NIH to: (1) optimize the biplex assays (2) establish a biorepository of 2000 clinical samples and ensure that one biplex meets the WHO TPP with greater than 95% statistical confidence and (3) progress the selected biplex to manufacturing and commercialization. By the end of this Phase 1/2 Fast-Track grant, a total of 100,000 assays will be available for testing by the TFGH, the CDC, and other stakeholders to generate the field data necessary to secure its international endorsement.